Characterizing protein condensates and nuclear organization in genomic integrity

PROJECT SUMMARY
All human cells integrate distinct DNA repair pathways and tightly control chromatin architectures to
prevent genomic instability. Disruption of these critical maintenance systems or defects in any one
pathway result in a mutational burden with profound physiological consequences. DNA repair in humans
is predominantly performed by two mutually exclusive pathways mediated by two distinct tumor
suppressors – homology directed repair (HDR) by BRCA1 and non-homologous end joining (NHEJ) by
53BP1. These tumor suppressors are examples of intrinsically disordered proteins (IDPs) containing
large stretches of low complexity protein sequences. 53BP1 undergoes liquid-liquid phase separation to
form biomolecular condensates in vitro and at DNA lesions and my work (during the K99 phase)
establishes the essential function of 53BP1 phase separation in NHEJ. In preliminary data, I show the
very first evidence that BRCA1 phase separates to form biomolecular condensates and identify a
putative prion-like domain for self-assembly. Nuclear organization and chromatin structure are also
vital parts of maintaining genomic integrity. DNA damage response requires dynamic rearrangements
and chromatin modifications to provoke rapid repair factor recruitment to lesions. Conversely, repair
factors and their complexes can also modify chromatin to drive repair programs. For example, recent
studies implicate 53BP1 in maintaining heterochromatin. Despite decades of study, it is only in the past
several years that condensation of tumor suppressors has been identified. While I have discovered that
BRCA1 phase separates, it remains unknown by what mechanism self-assembly occurs and what role it
plays in DNA repair through HDR. Further, the contributions of chromatin architecture to repair pathway
selection and chromatin organization involving tumor suppressor condensates have not been
characterized, leaving gaps in knowledge and possible therapeutic targets. Building on the K99 phase,
the goal of this work is to characterize tumor suppressor condensation and how chromatin homeostasis
contributes to genomic integrity. In Aim1, my lab will characterize the mechanisms by which BRCA1
phase separates into biomolecular condensates and how these ensembles influence DNA repair and
repair pathway choice (HDR vs. NHEJ). In Aim 2, my lab will use super-resolution imaging to directly
visualize and define, for the first time, the dynamic activity of chromatin in response to DNA damage and
how nucleosome remodeling contribute to 53BP1- and BRCA1-mediated repair programs. Collectively,
this work will address fundamental gaps in knowledge regarding the role of phase separations in genome
integrity and uncover new paradigms that underlie tumor suppressor activities.

Public health relevance
RELEVANCE. All cells must repair multiple DNA breaks rapidly and with precision to prevent genomic instability. Critical to this are the activities of tumor suppressor proteins and chromatin remodeling. Mutation or dysfunction of tumor suppressor activities or failure of precise chromatin charges are strongly linked to disease development, including many cancer types. This work investigates a newly identified activity of tumor suppressors, phase separation into condensates, in mediating DNA damage repair and how changes in chromatin impact DNA repair programs.